USC Roski Eye K12 Clinician-Vision Scientist Training Program (USC Roski Eye K12)

PROJECT SUMMARY/ABSTRACT
The USC Roski Eye K12 program will provide mentored research training along with didactic and practical
training to Scholars who demonstrate a commitment to a career as a clinician-scientist in vision research. USC
Roski Eye K12 Scholars will benefit from a constellation of assets: 1) immersion in the intensely academic,
highly innovative research environment at the USC Roski Eye Institute, ranked #2 in NEI funding; 2) research
training by a productive, well-established group of 32 Preceptors with successful mentorship track-records who
collectively hold 56 active NIH grants (including 30 R01s, 2 P01s, 5 U54, U01 or U10 awards, 5 P30 or P50
awards, and 2 T32s); 3) an experienced, capable and committed leadership team; and 4) a carefully designed
individualized curriculum that will equip Scholars with the research skills needed to become independent
clinician-scientists. Scholars will have the opportunity for research immersion in the following ophthalmologic
themes: Imaging, Bioengineering and Nanotechnology, Epidemiology, Inflammation and Regeneration, and
Neurodegeneration. The USC Roski Eye K12 proposes four aims: 1) Equip Scholars with skills to conduct
vision research by individualized, didactic research training; 2) Mentor Scholars to articulate incisive, important
research ideas, design scientifically rigorous approaches, critically analyze results and communicate research
findings; 3) Train Scholars to proactively foster a collaborative and multidisciplinary team approach to advance
vision research; and 4) Transition Scholars to develop independent and productive research programs. In
terms of deliverables, all Scholars will be expected to publish and present their research findings, and develop
and submit strong, scientifically rigorous, competitive individual mentored career development (K series) or
research (R series) grant applications. The USC Roski Eye K12 program, Scholars, and Preceptors will be
critically and regularly evaluated to ensure the program’s effectiveness in achieving the aims. The USC Roski
Eye K12 will thus produce talented, promising new ophthalmologist-scientists dedicated to becoming
outstanding, innovative, independent investigators who will address visual impairment and lead vision research
into the 21st century.

Public health relevance
PROJECT NARRATIVE The USC Roski Eye K12 will provide three years of mentored research training to Scholars committed to pursue careers as independent clinician-scientists in vision research. The program will engage experienced, well-established and productive faculty Preceptors to mentor Scholars, provide a unique curriculum individualized to the needs of each Scholar, and make accessible the rich research environment and distinct opportunities at USC for multidisciplinary and clinically impactful research. Scholars who complete the USC Roski Eye K12 will be prepared to develop successful and independent vision science research programs.